Controlling FKBP51 for the treatment of PTSD

Though physical wounds have been reduced in recent military conflicts, many Soldiers return
home with psychological wounds that manifest as post-traumatic stress disorder (PTSD), depression,
and other neuropsychiatric disorders. Some Veterans may be predisposed to these disorders due to
the presence of the common rs1360780 single nucleotide polymorphism (SNP) in the FK506-binding
protein 5 (FKBP5) gene, which occurs in about 50% of individuals. This SNP is associated with higher
expression of FKBP51, the protein encoded by the FKBP5 gene. Data suggest increased FKBP5
expression in the dorsal lateral prefrontal cortex (dlPFC) may be a driver of PTSD and increased FKBP5
levels are reported in the frontal cortex of PTSD patients. Excess FKBP51 dysregulates the
hypothalamic-pituitary-adrenal (HPA) axis, the central stress response system. Together, this supports
FKBP51 as a potential target for the development of therapeutics to treat PTSD and other
neuropsychiatric disorders. The overall goal of this proposal is to develop novel therapeutic strategies
to deplete FKBP51, using antisense oligonucleotides, and to validate FKBP51 as a target for regulating
resilience in PTSD using mouse models that lack or overexpress FKBP51 exposed to PTSD-like stress.
Trauma-induced neuropsychiatric phenotypes and molecular changes will be measured in these
studies.

Public health relevance
Some Veterans may be predisposed to post-traumatic stress disorder (PTSD), depression, and other neuropsychiatric disorders due to disinhibition of the FK506-binding protein 5 (FKBP5) gene. Excess FKBP51 dysregulates the central stress response system and increases susceptibility towards multiple stress-related mental health disorders. This supports FKBP51 as a target for PTSD and other neuropsychiatric disorders. Our goal is to develop novel strategies to deplete FKBP51 while validating FKBP51 as a key regulator of resilience/susceptibility towards PTSD-like trauma.